A novel Th17-enhancing adjuvant and conserved antigen for protection against viral/bacterial co-infection

We will develop a novel vaccine with broad efficacy against nontypeable Haemophilus influenzae
(NTHi) strains following influenza A virus (IAV) infection. NTHi is one of the most common pathogens
that cause secondary bacterial pneumonia following IAV infection. Although vaccines are available for IAV, they
confer very limited protection against viral and bacterial co-infection, and effective vaccines against NTHi remain
needed. NTHi vaccines under development focus on antibody responses that target bacterial surface proteins
and lipooligosaccharide antigens, which are hindered by genetic and antigenic diversity of NTHi strains and
there is no universally approved vaccine against NTHi. CD4+ T-helper 17 (Th17) cells are increasingly being
recognized as key mediators of protection against respiratory pathogen infections by production of IL-17A. A
preceding IAV infection decreases anti-bacterial Th17 responses, whereas established NTHi-specific Th17
memory cells can overcome Th17 inhibition and convey cross-protection against IAV/NTHi co-infection.
Adjuvants have been proven to enhance immune response strength and breadth, resulting in improved vaccine
efficacy. Therefore, focusing on Th17 cells and incorporation of Th17 adjuvants in vaccine strategies would be
effective in broadly protecting against co-infection. We have previously identified a conserved protein (protein
0259) from H. influenzae, that when administered as a vaccine, induces a cross-reactive, protective Th17
response against diverse NTHi strains alone and/or following IAV infection. Our preliminary data indicate that
an FDA-approved histone deacetylase inhibitor (HDACi), Romidepsin (RMD), acts as a novel adjuvant that
augments Th17 responses to vaccine and enhances protection against IAV/NTHi co-infection. These results
provide evidence that a vaccine candidate consisting of protein 0259 with the adjuvant RMD can be developed
into a novel mucosal Th17-based vaccine for clinical use. In this phase I STTR, we will perform proof of concept,
preclinical studies with the following aims: Aim 1. Establish the optimum antigen/adjuvant vaccine
dosage regimen to elicit potent anti-NTHi immune responses and evaluate its protective efficacy.
We will produce and purify Th17-inducing antigen to formulate a protein vaccine candidate consisting of this
conserved bacterial antigen (protein 0259) with a novel adjuvant (RMD) that induces strong anti-NTHi Th17
responses and will protect against IAV/NTHi co-infection. Vaccine dosage regimens that we have previously
found efficacious in mouse models will be compared to other administration strategies, including routes of
administration, the volume, and the dose. Successful immunization will be determined by detection of strong
antigen-specific Th17 responses. We will use the identified optimal vaccination regimen to protect against co-
infection in vivo, in comparison to our earlier immunization regimen. Aim 2. Conduct vaccine toxicological
assessments in mice. We will conduct toxicity studies of our novel Th17-inducing vaccine (protein 0259 plus
RMD), designed to provide pivotal safety data prior to human clinical trials. The aim will employ murine models,
chosen for their relevance to human immune responses, to thoroughly evaluate potential systemic and local
toxicity associated with multiple dosages of the vaccine. These studies are crucial for ensuring the safety and
efficacy of the vaccine, which represents a significant advancement in treatment/prevention of bacterial
pneumonia.

Public health relevance
PROJECT NARRATIVE Nontypeable Haemophilus influenzae (NTHi) frequently causes secondary bacterial pneumonia after influenza A virus (IAV) infection, leading to increased morbidity and mortality worldwide. T helper 17 (Th17) cells and IL- 17A mediate critical antibacterial responses and can recognize conserved antigens of NTHi. We will evaluate a candidate vaccine containing a Th17 inducing NTHi antigen that is conserved in all NTHi strains, along with a novel adjuvant, Romidepsin (RMD), to engage Th17 cell responses. This approach will confer broad protection against lung infection by diverse NTHi strains following IAV infection, reducing the need for antibiotic use.